Uncovering the rules of gut microbiome strain transmission

PROJECT SUMMARY
As biological scientists and even as members of an educated society, we all have some familiarity with the
fundamental concept that some aspects of our health are influenced by the set of genes we obtained from our
parents. We are also increasingly aware that our body surfaces, from our skin to our intestine, harbor microbial
strains that also influence our health. Given recent discoveries that many of our microbes are stably colonized
for decades and are acquired in early life, it is perhaps unsurprising that some proportion of the microbes
inside you right now were likely acquired from your parents and/or siblings when you were a child and
maintained in your intestine to this day, potentially influencing your health for these past many years. In
addition, we rarely find commensal gut microbial strains shared between two unrelated individuals outside of
extreme circumstances of microbial transfer such as fecal microbiota transplantation. Given the extreme
uniqueness of microbial strains at the genome level and the rarity of each strain variant, fecal microbiota
transplantation and familial-shared microbes represent the most efficient route to accurately track and infer
basic principles of microbial transmission and sharing. We feel this grant renewal will continue to address
important gaps in our basic science knowledge of gut microbiota transmission. Just as tracking of classical
acute pathogenic microbes plays a key role in disease prevention and treatment, uncovering the basic
principles of microbial sharing and transmission for non-acute pathogen microbes could enable new tools to
quantify disease risk, to understand the importance of the familial microbial strain sharing in disease risk, to
manipulate the gut microbiota to improve health, and ultimately perhaps to enable the prevention of disease
through controlled monitoring or therapeutic manipulation of the microbiota to minimize disease risk.

Public health relevance
PROJECT NARRATIVE The variation in gut microbiota strain composition between individuals is a major determinant of the functional impact of a gut microbiota on its host. However, we know little of how our gut microbiota strains are acquired, retained, or transmitted. Using a sensitive microbial strain tracking algorithm, metagenomics, and human fecal samples from fecal microbiota transplantation (FMT) recipients as well as fecal samples from families of various size, we will test hypotheses of how gut microbial strains are transmitted therapeutically in FMT and naturally in families to establish basic science principles of gut microbiome strain transmission.